Magnetoelastic Dynamic Midurethral Slings.

Project Summary
Stress urinary incontinence (SUI) affects up to 40% of all women, leading to a substantial reduction in quality of
life and annual costs of ~$10s bn in the United States. This condition is characterized by an undesired loss of
urine during activity, such as exercise, sneezing, or coughing. Among the current surgical treatment options, the
synthetic sub-urethral sling has gained wide popularity over the past 10-15 years. At present, sling materials
(e.g., polypropylene) placed beneath the urethra are permanently fixed. This static behavior is a leading
contributor to complications. Alternative SUI surgical treatments methods include artificial urinary sphincters,
which are invasive devices that pump fluids between a reservoir and a cuff to achieve dynamic forces around
the urethra. Due to this complexity and invasiveness, these devices are reserved as the last option to treat SUI.
The goal of this work is to develop a novel, shape-changing sling which is minimally-invasively placed, supports
and compresses the urethra to achieve continence, and can be activated to reduce the pressure on the urethra
to enable complete voiding. This reduction in support would be triggered using a handheld device either placed
above the urethra or inserted into the vagina in a tampon-like device. The assembled team is well qualified to
answer these questions based on multidisciplinary expertise The team has a history of collaboration and funding
and includes experts in biomaterials/soft actuators (Ware) and clinical management of incontinence (Zimmern).
Published and preliminary data, supported in part by an R21 on a different type of dynamic sling, demonstrate
the feasibility of creating magnetically responsive midurethral slings. Three specific aims are proposed: 1)
Fabricate and characterize magnetic elastomer slings with controlled mechanical properties, geometry, and
shape change when placed around a simulated urethra and in simulated scar. 2) Characterize the chronic
stability of the magnetoelastic slings and elucidate the effects of reversible shape change of chronically implanted
materials on the foreign body response. 3) Characterize the ability of the magnetoelastic slings to dynamically
alter leak-point pressure in a guinea pig model.

Public health relevance
Project Narrative Midurethral slings are medical devices that are implanted to support the urethra of women with stress urinary incontinence. Current devices are static. As such, the device frequently provides too much or too little support, which then causes complications or residual incontinence. This project investigates a new type of dynamic midurethral sling that can be actuated between a more supportive and less supportive form using a magnet.